SUPPLEMENT TO THE JOURNAL OF THE NATIONAL CANCER INSTITUTE (JNCI) MONOGRAPHS 50TH ANNIVERSARY ISSUE OF THE NATIONAL CANCER INSTITUTE'S SEER PROGRAM: A HALF-CENTURY OF TURNING CANCER DATA INTO DISCOVE

The SEER Program celebrates is 50th anniversary in 2023 and has contracted with the Oxford University Press to publish a special monograph within the Journal for the National Cancer Institute to include multiple articles on SEER, current work underway within the SEER Program and how SEER has impacted oncology.